Development and evaluation of human-friendly explanations for sepsis early-warning models

Project Summary
The goal of this Phase I project is to render a proprietary artificial intelligence algorithm for sepsis
prediction developed by Patchd, Inc., compatible with explainability capabilities, providing clinicians underlying
reasons for increased disease risk, as opposed to a “black box” risk prediction alone. The algorithm is
additionally innovative in that it imputes sepsis risk based on vital sign data gathered from wearable devices,
providing constant real-time surveillance of high-risk patients at home without requiring in-patient monitoring.
Sepsis has a high mortality rate of approximately 40% and often occurs in immunocompromised patients such
as those undergoing cancer chemotherapy, organ transplant surgery, or treatment for autoimmune conditions.
Catching the condition early remains the best way to reduce mortality as well as prevent the long-term health
effects associated with post-sepsis syndrome, which occurs in up to 50% of sepsis patients. Artificial intelligence
(AI) represents an intriguing means of identifying sepsis early. By compiling vital sign data from high-risk patients
and analyzing any changes in real-time, machine learning algorithms have shown promise in identifying at-risk
patients up to 8 hours before sepsis onset in hospital settings. While these predictive algorithms demonstrate
the power of AI in patient monitoring, most high-risk patients are treated via out-patient care without constant
vital sign monitoring. Patchd, Inc. has developed an AI algorithm for sepsis prediction which employs vital sign
data generated using wearable devices, such as watches or patches which record patient data in real-time. Thus
far, the algorithm has been shown to improve sepsis prediction accuracy and provide earlier warnings for sepsis
onset compared to other scoring methods. Recently however, bioethicists and regulators have called for AI
algorithms to pair their predictions with supporting explanatory information providing both clinicians and patients
more transparency when considering treatment options. During this Phase I program, Patchd will employ its
current algorithm architecture and add so-called explainability functions, revealing to the user which specific vital
sign dynamics impacted a given prediction. Vital sign data will be analyzed for local explanation functionality
using both kernel and deep SHapley Additive exPlanations (SHAP). Data will also be analyzed to evaluate the
significance of data points over time, using attentional mechanisms to understand the importance of vital sign
changes over time. Primary human data sets, comprising true-positives, true-negatives, false-positives, and
false-negatives, will be tested using the algorithm to evaluate both its predictive and explainabilty capabilities.
Given that sepsis impacts 1.7 million Americans each year, the Patchd approach to explainable sepsis prediction
will address a large and growing market opportunity.

Public health relevance
Project Narrative While AI algorithms have shown immense potential in guiding clinical decision making, their lack of transparency presents an ethical and regulatory challenge for patients, clinicians, and technology developers. So-called “black box” predictions provide insufficient information for clinical decision making, reducing the autonomy of patients, and presenting a risk to clinicians’ commitment to beneficence and non-maleficence. Patchd, Inc. has developed an AI algorithm design to predict sepsis risk during out-patient care, a crucial innovation for monitoring patients outside the hospital. Adding explainability capabilities to the Patchd algorithm will enable clinicians and patients to better understand why sepsis predictions are being made and, in keeping with ethical and regulatory standards, make more informed care decisions.